Program-level continuous design process with FEA support for medical devices

PROJECT SUMMARY / ABSTRACT
Our NIH R25 Education proposal’s main goal is to develop a continuous team-based medical device
design process incorporating clinical, business, and state-of-the-art features via the enhancement of
Hofstra University’s Bioengineering (BE) Program educational activities, culminating in the improved
Bioengineering Capstone / Senior Design Course experience. Through this approach, our BE
undergraduates including diverse and underrepresented minorities will have increased knowledge,
competency, practice, and modern skills that are vital to meet the workforce demands in biomedical and
healthcare technology industries. This innovative proposal of three design phases: Device
conceptualization, Performance evaluation using Finite Element Analysis (FEA), and Further
development in the Senior Design course, effectively extends the traditional one-semester course into a
productive three-year experience, allowing students to explore prototyping, translational, and business
aspects of matured device concepts.
The project’s Specific Aims are: 1) Offer real-world perspectives to design ideas, and 2) Strengthen the
design process education with FEA support. These will be accomplished through a collaborative clinical
immersion program for identification of critical patient needs and generation of device concepts early on,
mentorship of key professionals involved in medical device design, integration of Senior Design work to
multiple BE team-based design activities, extracurricular FEA workshops to further evaluate and iterate
the device ideas through computer simulation, and a website for storing and sharing of these activities.
We will evaluate the effectiveness of this innovative alternative approach based on three overlapping
batches of BE undergraduates as they navigate through their development and maturation of medical
device tasks over the project’s 5-year period.

Public health relevance
PROJECT NARRATIVE Bioengineering / biomedical engineering undergraduates develop and present their final team-based capstone projects in medical device design to integrate and showcase their skills learned throughout their 4-year program in a single-semester Senior Design Course. To enhance Hofstra University’s Bioengineering Program and to provide a more worthwhile educational experience to its diverse students and real-world relevance to design work, this proposal extends and integrates the medical design and development processes to: 1) team design activities of earlier coursework including to the computer simulation – finite element analysis (FEA) course, and added extracurricular 2) summer North Shore University Hospital clinical immersion, 3) collaboration with clinical, FDA regulatory, and business professional mentors, 4) FEA workshops with industry experts, and 5) informational website, providing continuity and increase in time, subject, and skills mastery. Enriching students’ educational experience to the real-world application and design activity integration produces better, more competent, ethical, and responsible biomedical and healthcare technology engineers with modern skills.